Environmental Career Worker Training Program

ECWT Program Summary/Abstract
The overall goal of WRUC’s Environmental Career Worker Training Program (ECWTP) is to
train individuals for jobs in the construction, environmental remediation, energy efficiency, and
hazardous waste fields with a focus on recruiting from historically disadvantaged communities
disproportionately affected by environmental exposures. WRUC accomplishes this goal through
comprehensive training and wrap-around services that reinforce worker health and safety and
job readiness to support both environmental and economic sustainability. In the next five years,
WRUC plans to recruit and train 135 participants per year from disadvantaged communities in
the cities of Los Angeles and Portland, and in remote tribal villages in Alaska. Our consortium
provides support to trainees through a program of consistent mentoring, from initial recruitment
to job placement and retention. WRUC has strategic partnerships in each location to sustain our
program’s ability to conduct outreach and recruitment, training, job placement, and tracking
activities. The program capitalizes on changing labor market demands and on green job career
pipelines in each target location.